Effects of arsenic and arsenic-containing mine tailings dust on airway epithelium and susceptibility to mold exposure

PROJECT SUMMARY (Project 1: Chen)
Chronic exposure to arsenic (As), commonly found in mine tailings particulate matters (mt-PMs), heightens the
risk of lung diseases. This risk is notably elevated for those living near contaminated sites due to continuous
exposure from inhaling dust and consuming tainted water or food. Additionally, environmental stressors, such
as mold, intensify these risks. At present, there is limited data about the mechanisms and effects of these
exposures, especially regarding nonmalignant lung diseases. In previously published research, we found that
As inhibited the production of major mucins, essential components for mucociliary clearance (MCC), in
differentiated human airway epithelial cells (HAECs). Moreover, mouse models exposed to inhaled synthetic
arsenic-containing dusts (sACDs) and real-life mt-PMs showed reduced CC16 expression, another crucial
MCC component. A decrease in CC16, a significant biomarker, is correlated with impaired lung function in
various diseases. Importantly, As appeared to repress retinoic acid (RA) signaling, leading to the
downregulation of both mucins and CC16. In our preliminary studies for this proposal, we extended the
previous findings by revealing that As-exposed HAECs underwent a process of de-differentiation. This change
resulted in the repression of several secretory and ciliated cell markers, suggesting a pronounced MCC
deficiency (MCCD) and a compromised epithelial barrier. Notably, all-trans retinoic acid (t-RA) could counteract As's effects, underscoring the significance of the RAR/RXR signaling pathway. Furthermore, Nrf2's
involvement was essential for RAR/RXR degradation, and a deficiency in CC16 rendered mice more
susceptible to mold exposure. Based on these insights, we hypothesize that As exposure induces MCCD in the
airway epithelium through a crosstalk between Nrf2 and RAR/RXR. This dysfunction likely weakens the
protective barrier, increasing susceptibility to environmental mold exposure. Therefore, we propose three aims:
1) To determine the mechanisms behind As-induced MCCD using single-cell RNA sequencing (scRNA-seq)
and delve into the Nrf2-RAR/RXR interaction. 2) To investigate how MCCD increases susceptibility to mold
exposure. 3) To compare the effects of sACDs with actual mt-PMs from Superfund sites, gauging their
potential risks. Our efforts aim to uncover the previously unexplored health implications of metal(loid) exposure and pinpoint molecular targets for creating risk assessments, addressing NIEHS SRP Mandates 1 and 2. By collaborating with various SRC projects and cores, we intend to present a comprehensive perspective on
metal(loid) toxicology, equipping communities with essential knowledge about the health hazards they might
face.

Public health relevance
PROJECT NARRAITVE (Project 1: Chen) Exposure to arsenic- or other metal(loid) containing dusts, often found in mine waste, raises the risk of lung diseases, especially for those living near contaminated areas such as superfund sites. Our research aims to understand how arsenic as well as other metal(loid) affects our lungs and why it makes individuals more susceptible to other environmental threats, such as mold. By uncovering these mechanisms, we hope to better inform communities of potential risks and develop strategies to safeguard their health.